Motherhood Biographies and Midlife Women's Health

Abstract
The Motherhood Biographies and Midlife Women’s Health R01 project maps how divergence in motherhood
experiences contributes to growing midlife health disparities. About 85 percent of midlife women today are mothers,
but pathways to motherhood—what we call motherhood biographies—are increasingly diverse across many dimensions
relevant to health, including age at first birth and spacing of children. The parent project tests how motherhood
biographies matter for midlife women’s health with a specific focus on race/ethnicity and socioeconomic status. We
compare mothers and non-mothers as well as mothers with differing motherhood biography profiles using nationally
representative data from the 1979-2018 waves of the National Longitudinal Study of Youth (NLSY79; N=4,951 women).
We are testing the following aims with this diversity supplement and Brantley’s efforts focused on Aims 2 and 3:
AIM 1: Identify how motherhood biographies—including childlessness—relate to midlife health. We are using
information on motherhood status, number/spacing of children, age and marital status at each birth, fertility
expectations, and pregnancy loss to identify motherhood biographies among women born 1957 to 1964 using Latent
Class Analysis and alternative methods (e.g., Sequence Analysis). We are examining associations between motherhood
biographies and physical, mental, and cognitive health and health behaviors at midlife.
AIM 2: Identify how the impact of motherhood biographies on health depends on characteristics of child-mother
relationship at midlife. Using mediation and moderation analysis, we are examining how child-mother ties in the
mother’s midlife both explain and shape associations between the motherhood biography and midlife health.
AIM 3: Identify the heterogeneous effects by educational attainment and race/ethnicity of motherhood biographies
on midlife health. Given the education-motherhood and education-health linkages as well as the race/ethnicity-
motherhood and race/ethnicity-health linkages, we are using moderation analysis to test whether motherhood status
and motherhood biography associations have heterogeneous impacts on midlife health by educational attainment and
race/ethnicity.
Given Brantley’s interest, the proposed supplemental project will focus on the race/ethnicity components of Aims 2 and
3. In doing so, this sub-project directly contributes to parent project aims related to race/ethnicity and health disparities
among women. Throughout the duration of the administrative supplement, Brantley will work with Thomeer (MPI),
Reczek (MPI), and the other team members and mentors to conduct research for publications, presentations, and other
research activates. Brantley will conduct analyses examining the dynamic and often complex relationship between
motherhood biographies and health across and within racial/ethnic groups, specifically among Black mothers. The entire
mentorship team will also assist Brantley in developing an NIH K01 application during the study period, as well as
present research at conferences and publish in peer-reviewed journals.

Public health relevance
Project Narrative The parent research project and proposed supplement is highly relevant to public health in its ability to determine the role of motherhood biographies as a key mechanism in explaining health disparities among midlife women, particularly Black women. This proposed supplemental research will identify the most health-disadvantaged subpopulations of midlife mothers and nonmothers with attention to differences by race-ethnicity. In doing so, this interventions and public policies designed to improve women’s health and reduce racial-ethnic health disparities in midlife and beyond, a key goal of NIA, while contributing to the development of a minority junior scholar.